Brain protein alteration by vascular overexpressed miRNA (BravomiR)

Significance: Alzheimer’s disease (AD) is the most common form of age-related dementia, affecting over 5.8
million Americans. Diabetes affects 34 million Americans (90-95% of which is type 2 diabetes, T2D), of which
1.5 million were newly diagnosed in the previous year. Most of these “new” cases were 45-64 years old, also
important to pre-AD etiology. About 88 million have pre-diabetes. Since comorbidity is common in humans, an
integrated study of AD and diabetes would have significant translational impact. Our goal to unveil specific shared
AD/T2D regulatory pathways is significant to lay groundwork for “co-treatment” of comorbid conditions
Rationale: Understanding co-regulation of the T2D-AD axis will be beneficial for two widespread interlinked
chronic disorders. AD neuropathology primarily consists of neuritic plaques of amyloid-β (Aβ) peptide, neuro-
fibrillary tangles of hyperphosphorylated tau (τ), neuroinflammation, and synaptic loss. Hyperglycemia increases
Aβ production. Other pathways that operate “through” T2D and “into” AD include brain insulin resistance, and
diabetes-triggered elevation of inflammation and oxidative stress, exacerbating Aβ and tau aggregation. Such
shared dyshomeostasis suggests shared dysregulation. One such dysregulatory avenue would be microRNAs
(miRNA), small non-coding RNAs that modulate translation of proteins from mRNA.
Hypothesis: Two specific miRNA species that are dysregulated in T2D (miR146a, miR200b) are also
dysregulated in AD, and significant AD-associated immediate and downstream effects accompany this co-
dysregulation. Approach: Combining non-genetic T2D animal models, pertinent (human neuronal and human
neurovascular) culture manipulation, and human AD samples (and control brains).
Aim 1: Test the hypothesis that T2D disruption of CNS protein levels is rescued by vascular expression of
miR200b/miR146a. We will test disruption of protein levels in mouse brains and rescue by miR146a and 200b.
Aim 2: Test the hypothesis that selected miRNAs directly interact with 3’-UTRs of AD-associated mRNAs. We
will characterize miR146a and 200b effects on AD-related proteins and show that activities of miR200b and 146a
in mouse models have counterparts in human-origin cells when treated with human miR200b and/or 146a.
Aim 3: Test the hypothesis that T2D and AD similarly disrupt selected miRNAs in human brains. We will
determine the extent to which miR200b and -146 are perturbed in T2D, AD, and T2D+AD autopsy brain samples.
Impact & Future Plan: We will discover and manipulate a network of shared miRNA dysregulation in all stages
of T2D/AD, allow regulatory progression of early disease stages to be known in parallel. We will study neuro-
pathology in miRNA overexpression/AD cross transgenic models and induced T2D in AD Tg models. We will
design experiments to track shared biochemical progression of T2D and AD, as well as T2D that does not
progress into AD. The overall impact is to develop intentional regulation of brain proteins alteration via vascular
overexpressed miRNA through peripheral administration.

Public health relevance
Alzheimer’s disease (AD) affects 5.8 million Americans, costing over $305 billion, and diabetes affects ~34 million Americans, of which 1.5 million were diagnosed in the previous year; epidemiological connections between type 2 diabetes (T2D) and AD suggest that T2D is a good predictor of transition from mild cognitive impairment to AD. Based on our novel finding that miR200b and miR146a share pathways of dysregulation in diabetes and AD and that vascular expression of miR200b may alter levels of AD-related CNS proteins, we now propose to test effects of inducing T2D in animal models on miR146a and miR200b deficiency and AD-associated proteins in the brain and rescuing these changes by inducing vascular overexpression of miR146a and miR200b, and to further assess AD and T2D effects on brain levels of these miRNAs, both singly and in combination. Since comorbidity is prevalent in humans, an integrated study of AD and diabetes, opposed to more conventional studies that look at each disease independently of each other, would have significant translational impact, which will lay important groundwork for true “co-treatment” of comorbid conditions and establish a means of intentionally altering brain protein levels via vascular overexpressed miRNA.